Ultrasound-mediated gene delivery to achieve therapeutic correction of hemophilia A

Project Summary
The goal of this proposal is to achieve long-term therapeutic correction of hemophilia A (HemA) via a noninvasive
protocol of ultrasound (US) mediated gene delivery (UMGD) of factor FVIII (FVIII) plasmids in the dog model.
HemA is a genetic disorder characterized by a deficiency of the blood clotting FVIII. Patients are treated acutely
or prophylactically by protein replacement therapy, which is very costly and inconvenient. Gene therapy is highly
promising for treating HemA patients by delivering hFVIII transgene into targeted cells to persistently produce
therapeutic levels of FVIII protein. Recent clinical trials for HemA gene therapy using recombinant adeno-
associated viral (rAAV) vectors have shown very promising results. However, significant obstacles remain to
prevent treatment to a significant portion of patients especially patients who have high-titer anti-AAV antibodies.
Repeated treatment is also prohibited. UMGD has emerged as an effective gene transfer approach with great
clinical relevancy and translational potential. In comparison to viral gene transfer, UMGD transfers plasmid
vectors that are easier to prepare and more cost-effective; it also elicits less immune response and toxicity due
to specific tissue targeting, prevents random integration, and allows for repeated delivery of the vectors. Other
nonviral gene delivery method such as DNA-packaged nanoparticle encounters the challenge of crossing the
nuclear envelope for DNA transcription. We have established a minimally invasive, transhepatic venous
approach to efficiently deliver plasmid DNA (pDNA)/microbubble (MB) mixture into the target liver lobe combined
with transcutaneous US applications in large animal models. We showed that high levels of luciferase reporter
gene expression were achieved in swine and therapeutic levels of FVIII expression was detected in canine0
using the clinically feasible protocol. Only transient tissue damages were observed and repaired quickly and
returned to normal within short time. However, in order to translate this novel technology to clinics, we recognize
that several major problems need to be solved, (i) higher FVIII expression levels are needed to achieve a long-
term therapeutic effect, (ii) persistence of therapeutic FVIII expression needs to be evaluated and maintained,
(iii) consistently high efficiency of US treatment on targeted liver tissue is needed to achieve reproducible and
efficient transfection. (iv) Better functional FVIII expression and reduced liver damage are desired. This may be
achieved by targeting FVIII transfection in liver sinusoidal endothelial cells (LSECs), the native site of FVIII
synthesis or by using newly synthesized nanobubbles (NBs). Thus, we propose to continue improving the
transcutaneous UMGD instrument, transducers, US protocols, FVIII plasmid constructs, and MBs/NBs in mice
and swine. Furthermore, we will deliver FVIII gene using the best transcutaneous UMGD protocol combined with
optimal plasmid constructs and MBs/NBs to achieve persistent and therapeutic levels of FVIII expression in
normal and HemA dogs. These progresses will promote the eventual translation of this novel technology into
human application, bringing significant benefit for treating HemA patients, and potentially other genetic diseases.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to develop a clinically feasible nonviral ultrasound-mediated gene delivery (UMGD) technology to bring significant benefit for treating hemophilia A patients, and potentially other genetic diseases. W have recently established a minimally invasive procedure to deliver the plasmid cargo in combination with transcutaneous application of therapeutic ultrasound to enhance gene transfer. This proposal will focus on further improving ultrasound system, transducer and protocols in combination with novel plasmid constructs and microbubbles/nanobubbles to improve gene transfer efficiency and safety to achieve a therapeutic effect to treat a diseased large animal model (hemophilia A dogs), which will will promote the next step of translation of UMGD technology into clinical applications.